Allele Specific Knockdown for LGMDD1

PROJECT SUMMARY / ABSTRACT
While the promise of gene-based therapies for disabling neuromuscular diseases is finally becoming a reality,
research efforts thus far have primarily focused on gene replacement strategies for recessive, loss-of-function
disorders. Such strategies are not translatable to most dominant muscular dystrophies, hindering the
development of new treatment strategies.1,2 Our group recently identified mutations in DNAJB6 that cause limb
girdle muscular dystrophy D1 (LGMDD1), a dominantly inherited disabling myopathy with no current treatment
options.3 The overarching goal of this proposal is to develop novel therapies for this devastating disease.
Addressing this unmet need will advance the field’s understanding of how to treat LGMDD1 and establish the
optimal approach to therapeutic development for other dominantly inherited disorders with complex,
heterogeneous disease mechanisms.1,2 Several lines of preliminary data indicate that mutations in DNAJB6
exert a dominant effect via a toxic gain-of-function.4,5 The potential for deleterious effects preclude a global
DNAJB6 knockdown strategy, as DNAJB6 knockout (KO) mice are embryonic lethal due to aggregation of
client proteins.6 Haploinsufficiency appears to be tolerated, as heterozygous KO mice are viable, with no
apparent skeletal muscle phenotype, and DNAJB6 frameshift and nonsense mutations are seen in healthy
“control” patients in genetic databases. We propose to selectively knockdown mutant DNAJB6 using silencing
RNA (siRNA). Our preliminary results indicate that allele specific knockdown (ASKD) is feasible and capable of
correcting a proteomic signature of LGMDD1 disease in vitro. Thus, our central hypothesis is that ASKD of
mutant DNAJB6 is a viable therapeutic approach to address the toxic gain-of-function mechanism of LGMDD1,
while avoiding complete knockdown. In this project we will validate that ASKD of mutant DNAJB6 improves
disease phenotypes in a LGMDD1 mouse model (Aim 1) and in vitro human LGMDD1 models (Aim 2). Finally,
we will optimize ASKD targeting a common DNAJB6 single nucleotide polymorphism (SNP) to expand the
applicability of this therapy to multiple DNAJB6 mutations (Aim 3). We have generated a knock in LGMDD1
mouse with a heterozygous p.F90I mutation, orthologous to human p.F89I, and a FLAG-tagged wild type (WT)
allele, enabling size-based distinction of WT vs. mutant RNA and protein. We also generated induced
pluripotent stem cells (iPSCs), gene-corrected isogenic controls, and primary myoblast cultures from LGMDD1
patients. Successful completion of the proposed aims will produce essential preclinical data supporting the
therapeutic translation of ASKD for LGMDD1.

Public health relevance
Project Narrative The limb girdle muscular dystrophy (LGMD) gene therapy field is focused almost entirely on recessively inherited disorders, leaving dominantly inherited LGMDs far behind in the path towards a cure. This project aims to develop allele specific knockdown using siRNAs as a therapy for LGMDD1, a disabling dominantly inherited myopathy, lacking any treatments. LGMDD1 is only one of several disorders amenable to the treatment strategies described in this proposal.